PIPELINE Facility Core

SUMMARY: PIPELINE FACILITY CORE
The Vision for the PIPELINE (Promoting Impact of Precision EHS by Leveraging Instrumentation,
NextGen and Emerging Technologies) Core is to provide access to expertise and technologies, and
facilitate effective utilization of “omic” technologies across the parent organizations of the Gulf Coast
Center for Precision Environmental Health (GC-CPEH) to advance environmental health science (EHS)
research. The PIPELINE Facility Core provides efficient systems level access, enabling researchers from all
Thematic Focus Areas to incorporate multiple NextGen “omics” technologies into their research. PIPELINE
provides services in 1) Genomics, Epigenomics and Transcriptomics, 2) Proteomics, 3) Metabolomics,
4) Microbiome and Metagenomics, 5) Cells-to-Tissues-to-Organisms, and 6) MultiOmic Data Analysis. To
support utilization, the PIPELINE Facility Core 1) provides consultation to Center members to identify the best
state-of-the-art technologies to meet their research goals; 2) works with members to ensure efficient project
design and comprehensive data generation; 3) delivers individualized training, and develops workshops and
Resource Educational Sessions; and, 4) provides robust bioinformatic analyses and data interpretation
integrating multiple platforms to ultimately provide systems-level knowledge. Importantly, resource access and
utilization are facilitated by subject-matter experts serving as Resource Navigators for GC-CPEH members.
Resource Navigators provide expertise, prioritize access, and assist members with project design, data
generation and bioinformatics analyses. This Core also supports the educational and mentoring needs of
members through individualized training, seminars, workshops, and participation in the Leadership
Development Program of the Center’s Career Development Program. Access and utilization of PIPELINE
services are facilitated via a Matching Funds Core Utilization Program, which significantly reduces the cost
of services. The following Specific Aims are designed to ensure the PIPELINE Facility Core achieves the goal
of advancing EHS research for GC-CPEH investigators and via cross-Center collaborations, EHS researchers
at other EHS Core Centers. Specific Aim 1: Provide high-quality, user-friendly NextGen resources to accelerate
precision environmental health research and increase the impact of GC-CPEH research; Specific Aim 2:
Contribute to the career development of promising new investigators and enable utilization of new technologies
by senior investigators; and Specific Aim 3: Increase the impact of the GC-CPEH research base by integrating
across Center components and institutions and contributing to exploratory Pilot Project research and high-impact
publications.